Molecular evolution of synthetic probes for orphan GPCRs

SIGNIFICANCE: G protein-coupled receptors (GPCRs) are the largest class of membrane proteins in the human
genome and are implicated in a wide array of cardiovascular and respiratory diseases. Notably, GPCRs are the
targets of one third of FDA approved therapeutics, including drugs prescribed for coronary heart disease,
hypertension, and asthma. However, of the ~800 known GPCRs, ~120 are orphan receptors (oGPCRs), which
are considered druggable targets but remain understudied in basic research efforts as they lack a known ligand.
Over the past two decades, extensive efforts to deorphanize oGPCRs have resulted in little turnout. It is evident
there is a need to increase the rate of discovery of ligands for oGPCRs. This proposal outlines a yeast directed
evolution platform for systematic, high-throughput discovery of antibody-based ligands for oGPCRs.
Deorphanizing a single oGPCR alone would open the door to understanding new biology and development of a
potential therapeutic agent.
BACKGROUND: oGPCR deorphanization efforts have been historically slow and low-throughput. Conventional
screens for oGPCR ligands can handle many targets, but due to the sheer amount of possibilities, including
protons, photons, lipids, hormones, peptides, and larger proteins, success has been limited. Nanobodies, or
small antibody fragments, offer distinct advantages for ligand screening, namely their suitability to directed
evolution. Directed evolution allows for billions of nanobodies to be screened for binding and modulation of
oGPCRs with a simple growth selection. Using a yeast-based hypermutation directed evolution platform, and a
precise, scalable, high-throughput continuous culture device, directed evolution campaigns can be scaled up to
ensure a deep search of nanobody sequence space.
SYNOPSIS OF AIMS: In this proposal are two related, but not interdependent aims. AIM1 establishes a
systematic workflow for the functional reconstitution of human GPCRs in yeast, which will (1) create a library of
yeast strains with orphan and non-orphan GPCRs, and (2) elucidate general guidelines to increase success
rates of GPCR expression in yeast. AIM2 takes oGPCRs found to be functional in yeast and uses them to run
directed evolution campaigns to discover nanobody ligands and validate these ligands in human cells. Both aims
can be developed in parallel, with results from AIM1 being progressively integrated into AIM2. Together, these
innovative platforms will lead to the deorphanization of many oGPCRs, thereby enabling the exploration of new
GPCR biology and pharmacology.

Public health relevance
PROJECT NARRATIVE GPCRs are the largest class of membrane proteins in humans and have been linked with many cardiovascular disorders. While GPCRs make up a third of all FDA-approved drugs, including for example widely prescribed anti-hypertensives, many potentially druggable GPCRs remain intractable because they lack known ligands to modulate their activity. Here, I propose a platform to systematically generate probes to modulate understudied GPCRs, which would serve as a steppingstone to study them and develop new therapeutic agents.